2022 Pediatric Research in Sports Medicine (PRiSM) Annual Conference

Project Summary
Since 2014, the Pediatric Research in Sports Medicine (PRiSM) Society Conference has occurred annually and
is a leading forum for the presentation and discussion of new, innovative, and cutting-edge collaborative research
and information dissemination in the field of pediatric sports medicine. As the only conference focused on
advancing knowledge on pediatric sports medicine with an interdisciplinary focus, our objective is to advance
our biological understanding of injuries and pathologies specific to pediatric athletes, and to enhance health for
this unique population of individuals. The conference format provides space and time built in for interdisciplinary
research collaboration discussions, learning from top experts in the field, and sharing the most recent findings
from individuals via podium and poster presentations. Furthermore, this conference has not only led to
discussions around the latest research advancements among individual research teams across the country, but
to collaborative publications by PRiSM members from different training disciplines and from different geographic
locations on topics such as Sports Specialization, Patient-Reported Outcomes, or Tibial Spine Fracture
Management. Furthermore, our emphasis on diversity since the inception of PRiSM has led to a robust program
that features clinicians and researchers from a variety of backgrounds and perspectives, all aimed toward
understanding how we can improve care for pediatric athletes. We are requesting funds for the PRiSM Society
Annual Conference, to be held in Houston, TX in 2022. Through this award, we will be able to provide student
travel grant opportunities to allow individuals to attend who otherwise would not have been able. Furthermore,
this will allow us to conduct our conference in a hybrid format of live, in-person attendance as well as the
capability to broadcast online so we can facilitate a robust discussion between those who are able to attend while
increasing accessibility to a broad array of professionals and trainees interested in pediatric sports medicine
research who cannot attend in person. Each 3-day annual meeting consists of 10 parallel scientific sessions, 3
keynote lectures, 2 sessions for research interest group members to discuss collaborative research projects, 3
poster sessions, and 2 parallel instructional course sessions geared toward integrating innovative evidence into
practice. Our demonstrated ability to provide a forum that advances knowledge while creating an environment
of inclusivity and accessibility indicates our potential to successfully achieve our aims through this proposal: 1)
To generate scientific content and programming highlighting the latest research and advancements in care within
the pediatric sports medicine community, and 2) to foster an environment of research collaboration among a
diverse set of professionals and trainees involved in pediatric sports medicine research.

Public health relevance
Project Narrative Pediatric sports medicine is a rapidly evolving field that contains many unique elements within clinical care and research, given that many pediatric sports injuries and conditions are unique to young athletes and do not occur in other age groups. The Pediatric Research in Sports Medicine (PRiSM) Society is dedicated to the care of pediatric and adolescent athletes, and our annual meeting provides a unique space for researchers, clinicians, and trainees from a variety of different backgrounds to gather and discuss barriers to clinical practice and ways to best address them. Through our unique approach to understanding condition-specific injuries and conditions within youth athletes and developing collaborative multi-site research projects (Research Interest Groups), the PRiSM annual meeting is a forum where interdisciplinary collaborations begin, grow, and produce meaningful advancements in the field.